Investigation of a Novel PDE4B Inhibitor for Stimulant Use Disorder

PROJECT SUMMARY
Fannin Partners is developing a drug, 11h, for the management of stimulant use disorders (StUD), an area of
major unmet medical need. Our key innovation is selective inhibition of a key inflammatory pathway in the brain
while reducing the adverse events associated with currently available non-selective inhibitors. StUDs have
increased rapidly in the last decade with stimulants now the 2nd most commonly used illicit substance (after
cannabis products), related to 75% of federal drug-related offenses. Methamphetamine (MA) is a stimulant with
high abuse potential and has become one of the most widely available and illicitly-used substances. Despite the
lack of specific therapeutics approved for StUD, inpatient treatment costs are estimated at ~$2.15 billion. Thus,
new treatment options are urgently needed - ideally orally available and with new mechanisms.
11h is orally bioavailable and shows promising efficacy in multiple animal models of substance use disorders,
including with cocaine, as well as anti-inflammatory activity. 11h appeared well tolerated in a variety of toxicology
models. 11h also demonstrated a favorable pharmacokinetic profile in animals with oral bioavailability and strong
brain penetration.
Here, we propose to further develop the drug through early pre-IND efficacy and toxicology studies. Our
experienced management team and key collaborators provide the environments required to successfully achieve
our proposed aims. We truly believe that this novel drug could potentially play a crucial role in saving lives and
reducing the current health crisis.

Public health relevance
PROJECT NARRATIVE The incidence and prevalence of methamphetamine and other stimulant use disorders have been steadily increasing to epidemic proportions, with no approved drug treatments available. Fannin is developing a drug with a novel mechanism of action that reduces neuroinflammation and has shown therapeutic potential in animal models of cocaine-use disorder. Here, we propose to further advance the compound through testing in preclinical animal models and complete further testing to demonstrate safety and efficacy and to prepare for eventual clinical testing.